Advanced transepithelial corneal collagen crosslinking

PROJECT SUMMARY
Keratoconus is an eye disease where the cornea is mechanically weakened, leading to
progressive thinning, distortion, and degradation of vision. In severe cases, corneal
transplantation may be required to restore vision. Corneal collagen crosslinking (CXL) is a
procedure that uses riboflavin, oxygen and ultraviolet (UV) light to produce a chemical reaction
that strengthens collagen fibers in the cornea stroma. CXL has been shown to halt keratoconus
progression over the long term.
A problem with the standard CXL procedure is that the surface epithelial cells must be
removed first so that riboflavin, oxygen, and UV can easily enter the corneal stroma. It is common
for epithelial healing to be delayed after CXL. This increases the chance that the cornea may
become hazy. It also increases the risk of infections that can lead to scarring and loss of vision. To
avoid these problems, some doctors perform CXL without removing the epithelium. This is called
“transepithelial CXL” in contrast to the standard “epi-off CXL” procedure. Unfortunately, as
currently practiced, transepithelial CXL is far less effective in strengthening the cornea.
We have developed an advanced transepithelial CXL technology (Casey CXL) that
overcomes the epithelial barrier to riboflavin, oxygen, and UV delivery. A computational finite-
element model (FEM) of diffusion and reaction kinetics showed that Casey CXL can significantly
exceed the performance of standard epi-off CXL. We propose to validate the advantages of
Casey CXL in ex vivo experiments using both rabbit and human eye bank corneas:
1. Construct an oxygen-UV delivery system to enrich oxygen to >90% in the ambient air over
the corneal surface during UV irradiation.
2. Measure oxygen concentration in the corneal stroma during CXL. We will use a fiber-optics
oximetry probe to measure oxygen in the anterior and mid-stroma during UV irradiation. We will
test the hypothesis that by using oxygen enrichment and pulsed UV, Casey CXL allows greater
oxygen penetration to the mid-stroma than standard epi-off CXL. The FEM predicts a more than
2-fold advantage for Casey CXL, which would greatly improve the depth of corneal strengthening.
3. Use optical coherence tomographic elastography, a nondestructive testing technology, to
measure cornea stiffness before and after experimental CXL. This would test the hypothesis that
Casey CXL can stiffen the cornea more than standard epi-off CXL, as predicted by the FEM.
These experiments would validate the Casey CXL protocol, including the drug formulation,
procedure steps, and oxygen-UV delivery device, to prepare for clinical trials in human patients.

Public health relevance
PROJECT NARRATIVE Corneal collagen crosslinking (CXL) is a procedure that can halt the progressive thinning and distortion of the keratoconic cornea, preserve vision, and reduce the need for corneal transplantation. This project will develop a novel transepithelial CXL procedure that will provide more effective corneal strengthening than the standard epithelium-off CXL procedure while leaving the corneal epithelium intact to improve safety, comfort, and visual recovery. This will be achieved by using a novel riboflavin drug formulation and soak-and-rinse protocol, a novel oxygen enrichment device, and an optimized pulsed ultraviolet irradiation regimen.